Mapping the functional GPCR-ome and its signaling consequences in neurons

Project Summary
Neuromodulators control the state of an animal’s brain and thus behavior through the activation of G protein-
coupled receptors (GPCRs). Although the role of neuromodulation has been appreciated for decades, the
chemical logic of neuromodulation has remained elusive due to inadequate tools to study it. Recent advances
in single-cell transcriptomics make it now clear that individual neurons co-express a huge diversity of
neuromodulatory GPCRs, yet GPCRs transduce signaling primarily by coupling to only three classes of G-
protein. This poses the question - does a neuron ‘know’ which of its many co-expressed receptors was
activated? And if so, how? I hypothesize that individual neurons are able to distinguish this chemical diversity,
even through shared signaling pathways, by utilizing spatiotemporal differences in GPCR signaling. To test
this, I will first determine which receptors are functionally co-expressed in primary hippocampal neuron
cultures, through a spatial-transcriptomic and functional screen. Then, I will compare response properties
focusing on Gs-coupled receptors by taking advantage of a powerful palette of biosensors to interrogate their
intracellular signaling with high spatial and temporal resolution. Finally, I will ask how these receptors are
utilized in intact circuits by using spatial-transcriptomics and live imaging of cellular activity in acute brain
slices. These findings will motivate my long term research goal of developing a subcellular understanding of
neuromodulation, which is key to understanding neural circuits in both healthy and diseased states. In addition,
this proposal includes a rigorous training plan and a team of collaborators that will bridge my research from
molecular to systems neuroscience. It includes training in quantitative and computational methods that will both
assist in my research aims and facilitate my development as a scientist. Through the excellence in research
and postdoctoral support at UCSF, the training environment in the von Zastrow lab, and the planned activities
listed in this proposal, this fellowship will prepare me for a career as an independent scientist invested in the
priorities of the BRAIN Initiative.

Public health relevance
Project Narrative The proposed studies aim to elucidate the chemical logic of neuromodulation by determining the implications of co-expression of receptors in primary neurons and intact brain tissue. This proposal utilizes the latest tools in transcriptomics, genetics, and live microscopy to better understand the diversity of cell types and neuron communication. The cellular understanding of neuromodulation gained will have important translational ramifications as neuromodulation is key to unlocking the brain in healthy and diseased states.